ENDOVASCULAR HORIZONS TESTING TO5. RESEARCH AND DEVELOPMENT FOR BIOCOMPATIBILITY TESTING, ANIMAL STUDIES, AND STERILIZATION TESTING IN THE BLUEPRINT MEDTECH (BPMT) INITIATIVE. 08/18/2025 - 02/17/2026.

The Blueprint MedTech program is an NIH incubator that aims to support the innovators by accelerating the development of cutting-edge medical devices for diagnosing and treating disorders of the nervous system. The mission of the program is to catalyze the translation of novel technologies from early-stage development to readiness for first-in-human clinical studies. By providing non-dilutive funding and access to essential resources, including planning support, design and testing services, and expert consultations on regulatory and commercialization issues, the program seeks to facilitate the translation of novel technologies to readiness for first-in-human clinical studies. Its goal is to enhance patient access to safe and effective medical devices while attracting further investment from industry and government. Medtech furthers the National Institute of Neurological Disorders and Stroke's mission to seek fundamental knowledge about the brain and nervous system and to use that knowledge to reduce the burden of neurological disease for all people.